Multi-level Factors that Influence Dialysis Facilities' Assessments of Patient Suitability for Transplantation

Project Summary/Abstract
For most patients with end-stage renal disease (ESRD), kidney transplantation is the optimal treatment.
Underserved racial/ethnic minority and low-income individuals have a greater burden of ESRD (higher
incidence and more rapid progression), yet they have much poorer access to transplant. Before patients are
considered for waitlisting at a transplant center, dialysis facility teams perform complex medical and
psychosocial assessments of patients' suitability for transplant and decide whether to refer them to a transplant
center for full evaluation. These pre-referral assessment processes, which vary widely across clinical teams,
have been identified as among the most important potential drivers of downstream disparities in transplant
waitlisting and receipt. The objective of this application for a NIDDK Mentored Research Scientist Development
Award (K01) is to support an assistant professor at the Emory University Rollins School of Public Health to
become an independent health services researcher fully equipped with the skills to build understanding of
these patient assessment processes and to improve their treatment outcomes. To that end, this K01 award will
provide training in clinical nephrology, qualitative and survey research methods, implementation science
frameworks, and grant-writing. The research aims are designed to reinforce and apply these new skills and
concepts in an investigation of dialysis facilities' pre-referral patient assessment processes. Specifically, the
K01's research objective is to use rigorous qualitative and survey research methods to elucidate the
measurable and modifiable provider-level constructs of cognitive load (stress, time pressure, disruptions) and
uncertainty tolerance (anxiety or worry in response to uncertainty) and their impact on disparities in pre-referral
assessments within their dialysis facility context. Aim 1 will use qualitative methods to explore how provider-
level factors (e.g., cognitive load, uncertainty tolerance) and multi-level contextual factors (e.g., facility-level
standard protocols, local transplant center policies) shape dialysis facility teams' processes for pre-referral
patient assessment. Aim 2 will develop and validate a survey to quantify staff, dialysis facility, and community
characteristics in the context of pre-referral assessments using a survey pilot and a rigorous modified Delphi
approach. Aim 3 will conduct a survey of n≈2000 dialysis facility staff across 13 states and use linked data on
patient transplant evaluation outcomes (referral, evaluation start, and waitlisting) to assess how staff cognitive
load and uncertainty tolerance are related to racial/ethnic and socioeconomic disparities in transplant access
as well as dialysis facility and community characteristics. The protected time, resources, and mentoring
available through this career development award will enable Dr. Adam Wilk to emerge as an independent and
leading researcher, conducting groundbreaking survey research and fostering the development and
implementation of multi-level interventions to address barriers in access to transplant or other preferred
treatments for underserved patients with kidney disease and other complex chronic conditions.

Public health relevance
Project Narrative Underserved racial/ethnic minority and low-income individuals with end-stage renal disease (ESRD) have relatively poor access to kidney transplantation, including in early stages of the process to obtain a transplant where the dialysis facility team's assessment of whether a patient is suitable for transplant is pivotal. This application will support an early-stage investigator seeking to become an independent researcher who will investigate these assessment processes, the multi-level (provider, facility, community, and region) factors that shape them, and their impact on patient-level transplant access and disparities. This K01 award will provide mentorship and rich training opportunities to develop new research skills and knowledge, enabling the investigator to conduct groundbreaking research in this area and foster the development and implementation of multi-level interventions that address barriers to transplant for underserved patients with ESRD.